The Role of HBeAg in HBV Persistence

ABSTRACT
Chronic hepatitis B virus (HBV) infection remains a substantial public health burden affecting approximately 296
million individuals worldwide and at least 1.2 million in the United States. Chronic hepatitis B (CHB) is one of the
leading risk factors of cirrhosis and the deadly liver cancer. Therefore, it is important to elucidate the mechanism
of HBV persistence and find a cure for chronic hepatitis B. The development of HBV persistence is due to the
failure of host immune system to clear the virus infection, and the longevity of the persistent form of HBV DNA
genome, namely the covalently closed circular (ccc) DNA in a nuclear episomal minichromosome structure. The
overall goal of this research project aims to elucidate the role of the understudied hepatitis B e antigen (HBeAg)
in HBV persistence. HBeAg positivity and its high titer reflect the high level of HBV replication and immune
tolerance in CHB patients. HBeAg seroconversion is usually considered to be a beneficial milestone and
evidence of reduced viral replication. In the prior funding period, we have revealed that the circulating HBeAg
inhibits host anti-HBV T cell responses via inducing the expansion of monocytic myeloid-derived suppressor
cells (mMDSCs), and the intracellular HBeAg intermediate p22 blunts IFNα-elicited JAK-STAT signal cascade
through blocking STAT proteins nuclear import. In the current project, we will focus on the intracellular events of
HBeAg to study the mechanisms of p22 biogenesis, interactome, epigenetic regulations of viral cccDNA
transcription and host ISG expression. The accomplishment of this project will shed new lights on the mechanism
of HBeAg-mediated HBV persistence, and ultimately lead to the development of novel therapeutics to cure HBV
infection.

Public health relevance
PROJECT NARRATIVE Chronic hepatitis B virus (HBV) infection is a substantial public health burden affecting approximately 296 million individuals worldwide. This project is to determine the role of intracellular HBV e antigen (HBeAg) in viral persistence, which will shed light on disease mechanism and treatment development. Therefore, our research is highly relevant to the public health interest.